UNC ARC Administrative Core

Administrative Core Project Summary
The administrative core of the UNC Alcohol Research Center entitled “MOLECULAR AND CIRCUIT
PATHOGENESIS IN ALCOHOL ADDICTION” is organized to foster and conduct interdisciplinary and
collaborative research on alcohol use disorders with a specific emphasis on molecular and circuit pathogenesis
underlying these disorders. In this renewal, we build upon the strengths of our Center by extending our
understanding of ethanol pathology mediated by dysregulation of neural circuits involving cytokine, dopamine,
dynorphin, GABA, glutamate, histone deacetylase and kinase signaling. The specific aims of the Administrative
Core are to provide scientific inspiration and administrative leadership for the Alcohol Research Center, monitor
and enhance interaction among the research components, optimize synergy and sharing of resources and
services, organize seminars and workshops to stimulate exchange of scientific information among the Center
faculty and staff. Further, we will work to stimulate new alcohol research programs at UNC, disseminate new
research knowledge to health professionals, academics, college students, families and youth in NC. The
Administrative core is involved in community outreach activities designed to improve awareness, prevention, and
treatment of alcohol use disorders. In addition, the Administrative Core oversees all budgetary issues,
appropriate allocation of funds as well as preparation of progress reports and the renewal of the ARC. In
summary, the administrative core is designed to maximize research rigor, significance, innovation, collaboration
and productivity to advance the research aims and to use scientific knowledge to improve health by educating
health professionals, parents, college students and youth.